Data Management and Analysis Core

Data Management & Analysis Core (DMAC) ABSTRACT
The Texas A&M University Superfund Research Center aims to develop descriptive models and
tools that can predict the possible hazardous outcomes of chemical exposure during environmental
emergencies while providing powerful solutions that can mitigate their negative effects on human
health. The Data Management & Analysis Core (DMAC) is one of the key components of the Center
that will support all projects and cores in their data management, analysis, quality control needs.
Directed by Dr. Efstratios N. Pistikopoulos and in collaboration with co-Investigators Dr. Fred A.
Wright, Dr. Lan Zhou, and Dr. Candice Brinkmeyer-Langford, the DMAC will provide a number of
essential services to the Center’s researchers by assisting them is achieving key environmental
and biomedical outcomes under four specific aims: (i) providing a new platform for data
management and sharing across the Center, (ii) applying best-practice analysis methods to Center
data, (iii) developing new methods that are urgently needed to solve the problems posed in the
Projects, and (iv) maintaining research and data quality control protocols for the Center. The DMAC
will establish a data universe (“dataverse”) for data sharing, integration, and collaboration. The
“dataverse” will be used to manage Center datasets where each component will securely deposit
and access data through a web-based platform and ensure Center generated data comply with
Findable, Accessible, Interoperable, and Reusable (FAIR) principles. The DMAC will also provide
additional assistance in developing and utilizing advanced data science methodologies for
translating raw experimental data into actionable insights and predictive models for all projects.
Project 1 will perform and optimize ion mobility spectrometry and mass spectrometry analyses of
complex environmental samples; DMAC will provide guidance on geospatial sampling, feature
selection, and classification analysis. Project 2 will develop in vitro pediatric lung model to
characterize respiratory risks from VOCs; DMAC will perform concentration-response modeling,
nonlinear, and spatial modeling techniques to evaluate the respiratory risks from ambient VOCs.
Project 3 will address pregnancy risk implications of exposures to hazardous substances by
developing a feto-maternal interface organ-on-a-chip model; DMAC will provide expertise in
hypothesis testing, regression analysis, and ANOVA testing for analyzing proinflammatory cytokine
measures. Project 4 will utilize in vitro cultures and reverse toxicokinetic analysis to characterize
hazards of environmental mixtures; DMAC will provide service in analyzing high-content screening
data, high-throughput transcriptomics data, and will perform population variability analyses. Project
5 will study the mitigation of adverse health effects of chemicals through broad-acting sorption
materials; DMAC will provide services for experimental design and statistical testing. The DMAC,
working in concert with the Research Experience & Training Coordination Core, will provide data
science training workshops for Center personnel. Finally, DMAC will develop Quality Assurance
Project Plans to cover all aspects of quality assurance and control for all Center components.

Public health relevance
Data Management and Analysis Core (DMAC) NARRATIVE The Data Management and Analysis Core of the Texas A&M Superfund Research Center serves as a hub for translating the raw experimental data produced by the Research Projects into useful knowledge to the community via data collection, integration, quality control, analysis, and model generation. The Core utilizes state-of-the-art methods in data science, optimization and machine learning, develops and applies novel dimensionality reduction techniques, and establishes a common data management and computational platform for collaboration within the Center and data dissemination to the Center stakeholders.